Creating Novel Interventions to Improve Prognostication for Patients with Hypoxic-Ischemic Brain Injury

Abstract
Sudden cardiac arrest is a leading cause of global death and disability. Most patients who are resuscitated
from cardiac arrest are initially comatose. These patients undergo neurological prognostication to estimate
recovery potential and death after withdrawal of life-sustaining therapies (WLST) based on clinicians’
predictions of a poor prognosis for awakening and recovery is common. Accurate prognostication allows
clinicians and surrogates to make informed decisions about WLST. Unfortunately, falsely pessimistic
predictions are common and lead to preventable deaths. Conversely, falsely predicting recovery potential can
result in prolonged, costly care and survival with unacceptable quality of life. Thus, preventing inaccurate
prognostication is critical to improve patient outcomes. Current approaches for neurological prognostication
after cardiac arrest are inadequate and in practice, clinicians perform poorly. Novel methods to improve
prognostication are urgently needed. The overall scientific objective of this career development award is to use
principles of decision science and organizational behavior to fill key knowledge gaps needed to create, refine,
and test targeted, rigorously designed interventions to improve prognostication, such as a team-based
approach. The career development objectives will allow the applicant to refine her expertise in decision
sciences, organization behavior, innovative clinical trial design, and social determinants of decision-making. In
doing so, this award will support a career of sustained high-impact science. The project leverages the strength
of an outstanding mentorship team with world experts in medical anthropology, decision, team, and
resuscitation sciences, a rich environment, and the applicant’s prior experience and academic successes. Aim
1 will use rigorous mixed methods (concept mapping) to identify key metrics of prognostication quality by
engaging a diverse community of stakeholders of cardiac arrest (physicians, non-physician clinicians,
survivors, co-survivors, and surrogates of decedents) and domain experts in ethics, legal/policy, and
religion/spiritualism. Aim 2 will identify clinical situations where experts disagree about prognosis because in
these challenging cases novel strategies are most urgently needed. Aim 3 will use a decision science
approach (signal detection theory) to compare prognostication by individual experts and teams of varying
compositions, providing preliminary data supporting the efficacy of a team-based approach and identifying
which team composition characteristics need to be optimized to maximize efficacy. Taken together, this award
will advance the applicant’s goal of becoming an independent clinician-investigator who transforms outcomes
of patients with severe acute brain injury by creating and testing high-impact interventions that improve
prognostication quality.

Public health relevance
Project Narrative Cardiac arrest can cause coma from severe brain injury, ultimately resulting in death when doctors believe there is a poor prognosis for meaningful recovery and recommend life-sustaining therapies be withdrawn in favor of palliative measures. Unfortunately, predicting outcomes of comatose post-arrest patients is difficult, doctors are often mistaken when they believe there is no recovery potential, and thousands of lives are lost annually because of inaccurate prognostication. This project will address this crisis by answering three key questions: what factors matter most to patients, caregivers and clinicians during prognostication after cardiac arrest; in what clinical circumstances is it difficult for expert doctors to predict patient outcomes; and, might a team-based approach to prognostication solve this challenging problem?